Development, Validation, and Application of Structure-based Tools for Computational Molecular Design

PROJECT SUMMARY/ABSTRACT
The central objectives of this research proposal are "development" and "validation" of methodologies to
algorithmically encode underlying physical observables to improve design of small organic molecules for a
biological target and their "application" to real world systems. Computational modeling at the atomic-level
empowers understanding of the factors that drive molecular recognition and enables testable predictions that
can be confirmed by experimentalists. Grounded in strong results and data, we hypothesize that major gaps in
the field (i.e. pose accuracy, enrichment, protein flexibility, specificity, site complementarity, ease of use) can
be bridged through forward-thinking design of tools that improve sampling, scoring, and searching. A major
undertaking is development of a new platform for "de novo" design which will enable "from-scratch"
construction of novel molecules, which removes the limitation of only considering those that are preconceived.
This will enable design of compounds highly "optimized" and "specifically tailored" to the protein of interest.
Our approach employs construction of molecules starting from user customizable libraries of building block
fragments using algorithms we developed and implemented into the program DOCK6. New advances will be
made available to the research community through public releases along with validation databases and user-
friendly online tutorials. Without inventive approaches to ligand discovery, there is a high likelihood that certain
areas of chemical space may not be adequately sampled by standard screening methods which provides the
rational. Our expected outcomes are ensembles containing highly specific and optimized ligands. The proposal
is framed around 4 fundamental questions: (Q1) What underlying physical principles that drive molecular
recognition (binding, selectivity, resistance) can be captured at the atomic-level and used to design improved
software and simulation protocols for accurate prediction of geometry and energy? (Q2) Can ligand growth be
propelled to highly specific regions of chemical space through "from-scratch" assembly of small organic
fragments (de novo design) using "molecular mimicry" principles to direct the growing ensemble as it evolves?
(Q3) Which sampling, scoring, and searching methods are most effective for identification and design of
verified-active compounds and can more effective practices be developed to maximize overall "success" in
collaboration with experimentalist? (Q4) Can docking and de novo design software and protocols be designed
to be more user friendly while not sacrificing accuracy or power? We will collaborate with a network of
experienced experimental labs and employ our new tools to make predictions. We will identify small molecule
probes and inhibitors to answer basic research questions and provide mechanistic understanding for biological
systems of relevance to human health including: fatty acid binding protein, nSMase2, neutral ceramidase,
HIVgp41, GP2, glycoprotein-E, ErbB-family mutants (EGFR, HER2), candid albicans Glx3/Hsp31, and human
Tsg101, among others. Experimental outcomes in turn will inform our further method development efforts.

Public health relevance
PROJECT NARRATIVE Atomic-level computer modeling allows prediction of molecular recognition which can enable greater understanding of biological systems relevant to public health. In this project we develop and validate new sampling, scoring, and searching techniques to increase the accuracy and ease of use of structure-based design with a focus on docking. In parallel, we are creating a new molecular assembly platform to facilitate from-scratch construction (de novo design, genetic algorithm) of small molecules with properties customized to the binding site(s) being targeted. We apply our tools to make testable predictions in collaboration with experimental groups, and we make them widely available to the research community.